Roles and therapeutic potential of CD150high niche-associated regulatory T cells in bone marrow injury and engraftment

Project Abstract
Although the stem cell microenvironment, or the niche, has been extensively studied as a site which regulates
stem cell functions, immunological attributes of the niche have been largely unexplored. Interestingly, studies
conducted over six decades ago revealed that the locations of germline and embryonic stem cells, the testis
and placenta, immunological sanctuaries for stem cells, termed immune privileged (IP) sites. In these tissues,
transplanted allogeneic or xenogeneic grafts can persist without immune suppressive therapy, distinguishing IP
sites from other sites. Little is known about whether tissue-committed stem cell niches serve as IP sites. Our
recent studies demonstrated evidence suggesting that the HSC niche within the bone marrow (BM) is an IP
site. We showed that unique FoxP3+ regulatory T cells (Tregs) with high expression of an HSC marker,
CD150, frequently localized adjacent to HSCs. These Tregs enabled persistence of allo-HSCs in non-
conditioned immune competent mice without immune suppression. In non-transplantation settings, niche Tregs
protected endogenous HSCs from oxidative stress, maintaining HSC quiescence. These observations suggest
that niche Tregs endow HSCs with immune privilege. To promote translation of our findings into clinical
settings, we will propose to study roles and therapeutic potential of niche Tregs in hematopoiesis failure
following irradiation and in allo-HSC engraftment following non-myeloablative conditioning. We will characterize
niche Tregs' stress-resistance, repopulating potential, molecular signatures, and T cell receptor (TCR)
repertoire, assessing how these features of niche Tregs contribute to HSC protection or engraftment.
Successful studies will identify unprecedented Treg subsets which act as stem cell protectants from immune
attack and stress within the niche, decipher mechanisms of this niche Treg-mediated stem cell protection or
engraftment, and lead to development of promising therapeutic strategies for post-irradiation BM injury or
engraftment by transferring or manipulating niche Tregs. Therefore, the results of our proposed studies will
eventually improve outcomes of allo-BM transplantation or radiation therapy for patients with blood disorders,
immune deficiency, metabolic diseases, blood malignancies, and solid cancers.

Public health relevance
Project Narrative We have recently identified immune suppressive lymphocytes which possess a unique function to protect blood stem cells within the bone marrow. The goal of the proposed project is to test whether these immune suppressive lymphocytes I) protect blood stem cells from radiation therapy or II) help transplanted blood stem cells to produce blood stem cells. Successful studies will lead to new strategies to increase chances of successful allogeneic blood stem cell transplantation or radiation therapy for patients with blood disorders, immune deficiency, metabolic diseases, blood malignancies, and solid cancers.